Accelerating Functional Maturation of Human iPSC-Derived Astrocytes

Project Summary/Abstract
Neurological and psychiatric disorders, including Alzheimer’s disease, exert a devastating personal and
economic toll on patients, families, caregivers, and society. This is in part due to our failure to develop effective
medications, reflecting drug discovery platforms that are often not relevant to target diseases. The recent
development of induced pluripotent stem cells (iPSCs) from humans makes it possible to screen and validate
candidate compounds on human brain cells, including those from patients, thus potentially increasing the
success rate and speeding the pace of CNS drug development.
BrainXell, Inc. has pioneered the development of human patient brain cell-based platforms for CNS drug
discovery. Functional loss or impairment of astrocytes is implicated in a wide range of pathological processes
and neural disorders, including Alzheimer's disease, Huntington’s disease, and amyotrophic lateral sclerosis.
We developed a novel method for rapid generation of enriched and functional astrocytes from iPSCs in four
weeks by applying inducible expression of gliogenic transcription factors NFIA and SOX9. However, iPSC-
derived astrocytes are immature, comparable to those at the fetal stage, which makes it difficult for presentation
of disease phenotypes and for high-throughput screening (HTS) for drug leads intended for those whose brains
are fully mature. The goal of this Phase I SBIR project is to uncover molecules that speed the expression of
genes associated with a mature state in iPSC-derived astrocyte and to formulate cocktails that yield mature
astrocyte within 1-3 weeks after plating. We will engineer a human iPSC reporter line with nanoluciferase (Nluc)
fused to EAAT2 (encoded by the SLC1A2 gene), a glutamate transporter highly expressed in mature astrocytes.
This line will enable and simplify the screening of small molecules for accelerating astrocyte maturation.
Formulation of an effective cocktail for rapidly generating mature human astrocyte will remove a major roadblock
in establishing human patient astrocyte-based HTS for CNS drug development.

Public health relevance
Project Narrative BrainXell will develop technology to accelerate the maturation of human stem cell-derived astrocytes similar to those that reside in the human brain. These cells will enable more predictive drug screening on a large scale, thus aiding in the discovery of new drugs for treating neurodegenerative disorders such as Alzheimer’s disease, Huntington’s disease, and amyotrophic lateral sclerosis.